Psychometrics and Predictive Validity of Infant Learning

PROJECT SUMMARY
The ability to detect sensorimotor contingencies between an organism's actions and changes in the
environment is essential to survival, impacting social, motor, affective, and cognitive domains. Operant
conditioning paradigms provide a direct measure of contingency learning, and are amenable for use
throughout infancy. The primary goal of this research is to determine whether individual variations in
contingency learning are consistent or correlated across tasks and/or across development, and to determine
whether these measures predict future standardized measures of cognition. To this end, we will longitudinally
test infants from 6-18 months using two established infant operant conditioning tasks—the synchronous
reinforcement paradigm and train task—each involving a different response system (looking vs. lever pressing)
and reinforcer. Despite the fact that learning is universally regarded as a fundamental component of human
behavior, after over a century of behavioral science, we simply do not know whether or to what degree
individual differences in measures of learning in infancy are consistent psychometrically, or whether they are
directly associated with broader cognitive and language outcomes. There is substantial demand for the
inclusion of measures of learning in clinical trials as potential outcomes for early interventions, but these
fundamental issues have never been previously established or investigated in infancy. This proposal features
two investigators with direct expertise in operant learning paradigms for infants and in conducting longitudinal
projects; here, they seek to establish the fundamental psychometric properties of individual differences in
classic parameters of operant conditioning within ages across tasks and across ages, and to establish the
developmental course of these parameters. We also seek to determine the predictive validity of these
individual differences, whether the indicators themselves or their developmental functions are predictive of
standardized 24-month outcomes. We propose to use two paradigms that utilize different operants (looking
and motor actions) each of which have previously been established as valid and workable in published
literature. Learning within traditional conditioning paradigms has long been neglected in the area of human
infancy; this study has the potential to resurrect learning in infant studies and developmental science. Given
that differences in contingency learning have been noted in at-risk infant samples and learning is often used in
preclinical animal work, this work would serve to provide a connection between preclinical studies and clinical
trials. Our findings will have critical implications for the use of learning in clinical trials and long-term outcome
studies.

Public health relevance
PROJECT NARRATIVE This research seeks to collect basic information about the development of learning in infancy: how learning develops from 6 to 18 months of age, whether infants who learn, remember, and relearn quickly on one learning task or at one age also learn, remember, and relearn quickly on another task or at another age. Finally, this work will establish whether infant learning is related to cognitive and language development at 2 years of age. This research is relevant to the identification of infants at risk for developmental disability and delay, and has the potential to improve the evaluation of attempts to enhance human development with early interventions.